ASO Therapy for ADNP

PROJECT ABSTRACT
This proposal will lay the foundation for developing a molecular therapy for ADNP Syndrome. Also known as
Helsmoortel-Van Der Aa Syndrome, ADNP Syndrome is a neurodevelopmental disorder characterized by
severe intellectual disability, a myriad of motor dysfunctions, autism spectrum disorder, impaired sensory
processing, seizures and sleep disturbances. ADNP Syndrome has an incidence of ~1:10,000 live births but
accounts for ~0.2% of autism diagnoses, labeling ADNP as one of the highest causal risk genes for autism
spectrum disorder. ADNP Syndrome is caused by mutations in Activity Dependent Neuroprotective Protein
(ADNP), a chromatin modifier that affects over 400 genes during embryonic development and thousands
postnatally. The mutations occur de novo, many of which are heterozygous haploinsufficient loss-of-function
(LoF) mutations. This suggests that one approach to therapy could be to rescue the haploinsufficiency by
increasing the amount of ADNP protein.
Through private pilot funding, we have created antisense oligonucleotides (ASOs) that are able to increase
ADNP protein expression in iPSC-derived human neurons. The presumed mechanism of action, blocking
unproductive upstream open reading frames (uORFs), will be tested in Aim 1 of this proposal. Also, because
mice do not have the same uORF structure as in human, the ASO cannot be tested in a mouse model. We have
therefore designed a fully humanized ADNP mutant mouse model. An initial characterization of the molecular
features of this model will be investigated in Aim 2 of this proposal to demonstrate its utility for ADNP therapeutic
development. The results of the proposed study should provide foundational preliminary data to support more
substantial subsequent studies to create the first ever ASO therapy for ADNP syndrome. The results from this
study will further advance the translational potential for precision therapeutics for children suffering from ADNP
and other genetic haploinsufficient disorders.

Public health relevance
PROJECT ABSTRACT Rare disease affect more people than cancer and AIDS combined, but only 5% have any kind of treatment. Antisense oligonucleotides (ASOs) offer great hope because they are relatively simple and can be developed quickly. This project will start the path to a molecular therapy for ADNP syndrome.